FOLLOW-UP OF VERY LOW BIRTH WEIGHT INFANTS BORN AT UNIVERSITY HOSPITAL

The two year growth and developmental outcome of preterm infants is related not only to perinatal events but also to subsequent management and illnesses. This study will examine this hypothesis.